Administrative Core

Project Summary: Administrative Core
This BRAIN Initiative proposal on “Oxytocin Modulation of Neural Circuit Function and Behavior” will be located
at NYU School of Medicine, and each of the four Project team labs (Tsien, Buzsaki, Lin, and Froemke) are
housed within the Neuroscience and Skirball Institutes at NYU School of Medicine and NYU Langone Health.
This proximity facilitates their interactions, already leading to a number of collaborations that collectively form
the foundation for this proposal. Our team studies and activites will therefore benefit from integration with the
larger NYU scientific environment, including the Neuroscience and Physiology graduate program, an existing
and robust scientific outreach program, and insititional resources including a cutting-edge health science library
and data management system together with a world-class biostatistics department.
This Administrative Core will help ensure the management, coordination, and interactions between these
components of this proposal. Aim 1 of the Administrative Core is to enable productive and synergistic interactions
between Project team labs, by organizing the Internal and External Advisory Committees, and scheduling regular
meetings for open communication, troubleshooting, and sharing of scientific results. Aim 2 is to enhance the
scientific training and careers of junior colleagues in team labs, including graduate students, postdoctoral fellows,
and technicians, by co-advising and interactions with NYU training programs. Aim 3 is to ensure that our results
are clearly communicated in a timely manner to NIH staff, other scientists, and the public. We will build and
maintain a website to feature team members, activities, and discoveries. Our labs are committed to data sharing,
and we will work with the proposed Data Science Core on these efforts. The NYU Neuroscience graduate
program has substantial connections with high schools and museums throughout New York City, and engages
in activities both statewide and national (particularly through the Society for Neuroscience). Finally, Aim 4 will
ensure the appropriate management of Project and Core finances and the overall budget. Administrative Core
Co-Directors and staff members are highly experienced at managing multi-PI projects and budgets.These aims
of the Administrative Core will help maximize Project team productivity, enabling synergistic and accelerated
scientific progress across team labs, and effectively communicate our findings to the greater scientific and lay
community.